Isolating and mitigating sequentially dependent perceptual errors in clinical visual search

Remote-store-and-forward teledermatology has grown exponentially in popularity as an efficient, accurate, and
cost-effective way to improve the health and well-being of millions of patients around the world. In remote store-
and-forward teledermatology, clinicians are asked to recognize and classify images of skin lesions and make
visual judgments about lesion features and malignancy. Dermatologists performing screening in this paradigm
can examine hundreds of images, seeing them one after the other. A central underlying assumption of this task
is that dermatologists’ percepts and decisions about a current image are completely independent of prior events.
Recent results show that this is not true: our perception and decisions are strongly biased by our past visual
experience. Although serial dependencies were proposed to be a purposeful mechanism to achieve perceptual
stability in natural vision, serial dependencies in remote store-and-forward teledermatology could play a crucial
and deleterious role in cancer screening. For example, a malignant lesion could be classified as benign
depending on the content of the previously seen image. Given the importance and impact of serial dependencies
in dermatological settings, we plan to (1) establish, (2) identify, and (3) mitigate the conditions under which serial
effects determine percepts and decisions in a remote store-and-forward teledermatology setting. In Aim 1, based
on preliminary and pilot data that indicate a clear detrimental role of serial dependencies in clinical visual
judgments, we plan to test the full impact of serial dependencies on lesion recognition, including four common
tasks: malignancy classification, lesion symmetry perception, lesion homogeneity perception, and lesion border
discrimination. In Aim 2, we plan to identify the specific boundary conditions under which visual serial
dependence impacts visual recognition in store-and-forward teledermatology. In Aim 3, we will use the boundary
conditions identified in Aim 2 to propose a series of task and stimulus manipulations to mitigate the deleterious
effects of visual serial dependence on lesion recognition. As a result of these manipulations, performance should
improve in measurable ways (including sensitivity, specificity, accuracy, and d’). Aim 3 is particularly crucial
because it will allow us to propose new guidelines that will greatly improve lesion recognition in remote store-
and-forward teledermatology screening. Taken together, the proposed studies in Aim 1, 2, and 3 will allow us to
establish, identify, and mitigate the deleterious effect of serial dependencies in remote store-and-forward
teledermatology tasks, which could have a significant impact on the health and well-being of skin cancer patients
around the world.

Public health relevance
Project Narrative (three sentences) Our proposal will investigate the detrimental impact of visual serial dependencies in remote store-and-forward teledermatology, which could lead to misdiagnoses of skin cancer and other dermatological conditions. Serial dependencies significantly impact our perceptual experience, but little is known about their detrimental consequences when dermatologists are asked to recognize images of lesions in a remote store-and-forward setting. Crucially, the goal of our research project is to develop recommendations and guidelines to mitigate the deleterious effect of serial effects and, thus, improve diagnostic accuracy in store-and-forward teledermatology.